The role of CFTR during macrophage-mediated killing of bacteria

PROJECT SUMMARY
Why patients with cystic fibrosis (CF) continue to suffer from chronic bacterial infections despite
new medications that improve CF transmembrane conductance regulator (CFTR) function is not
known. The long-term goal is to develop therapeutics that modulate host immune responses
in CF patients to mitigate chronic infection and inflammation. The objective of this proposal is to
define how CFTR regulates macrophage function. The rationale underlying this proposal is that
our prior work demonstrates that CF macrophages are integral to the inability of patients with
CF to clear bacterial infections through failed NADPH oxidase (NOX) assembly and reduced
autophagy. The central hypothesis is that loss of functional CFTR in human MΦs inhibits NOX
assembly and subsequent ROS-mediated autophagy, independent of CFTR mutation class, but
worsened by specific opportunistic bacteria. Further, we expect that a critical threshold of CFTR
function is needed to reverse the NOX assembly/autophagy deficits and can be re-established
by CFTR modulators combined with alternative CFTR restoration agents such as cysteamine or
our novel autophagy stimulator, AR-13. The central hypothesis will be tested by pursuing
three specific aims: 1) Define the mechanism by which CFTR regulates MΦ NOX assembly; 2)
Determine how CF specific pathogens differentially regulate MΦ ROS production; 3) Determine
the extent to which novel therapeutic approaches alter the MΦ NOX/autophagy axis. We will
pursue these aims using an innovative combination of genetic and pharmacologic techniques in
human macrophages. The proposed research is significant because a precise understanding
of how CF macrophage function is regulated would allow novel antibiotic- and CFTR mutation-
agnostic treatment approaches to infection. It is also significant because it will determine if
specific pathogens independently contribute to deficits in macrophage-mediated bacterial killing.
The expected outcome of this work will establish a mechanistic framework to enable us to
target and correct defective CF MΦ-mediated bacterial killing. Ultimately, we will translate this
new knowledge into a new treatment paradigm that uses innovative host-directed therapies to
combat bacterial infections.

Public health relevance
PROJECT NARRATIVE Cystic fibrosis (CF) remains one of the most common, life-limiting genetic disorders due to chronic bacterial lung infections that do not respond to traditional antibiotic therapy. The proposed research will achieve a thorough understanding of how the immune system fails to respond to bacterial infections in CF in order to develop targeted therapies to prevent life- limiting bacterial lung infections. The proposal is relevant to public health and the NIH's mission as the findings will impact the treatment and understanding of immunodeficiencies and lung diseases associated with chronic bacterial infections.